CE25-026 - An Impact Evaluation of the Monique Burr Foundation Teen Safety Matters Prevention Education Program

Project Summary Abstract
Child sexual abuse (CSA) and problematic sexual behavior (PSB) among youth are pervasive public health
issues with significant physical, emotional, and societal impacts requiring community-level interventions. This
evaluation is a field experiment designed to test the effectiveness of Teen Safety Matters (TSM), a school-
based prevention program developed and implemented in multicultural school settings to equip both middle
school adults and students with the knowledge and skills to identify and prevent CSA and PSB. This
researcher-practitioner partnership will be conducted in a community population (New York City Public
Schools) that is not only racially and ethnically diverse, but also serves learners who are predominantly
economically disadvantaged (four out of five) among other vulnerabilities that confer disproportionate risk of
CSA and PSB. The program evaluation has three specific aims: (1) Conduct a randomized controlled trial to
assess the effectiveness of the TSM program on middle school students’ CSA and PSB outcomes; (2)
Investigate the durability of TSM effects throughout middle school and into the first year of high school; and (3)
Assess the differential impact of TSM on student outcomes by demographic subgroups. The study will engage
40 middle schools which will be randomized into one of two experimental conditions—TSM for students and
school adults (Condition A), TSM for school adults only (Condition B)—or to the control condition (business as
usual) in which school are eligible for delayed rollout. Data will be collected from adults and students at
baseline, after one year, after two years, and (for the two older student cohorts) during high school. The
primary adult outcomes are their preparation and actions for the prevention of CSA and PSB. The primary
student outcomes include program effects on their knowledge, social-emotional competencies, skillsets and
safety outcomes relevant to the prevention of PSB. Analyses of the outcomes for participants in Condition B
will yield insights about the value of extra training for school adults to shift the middle school environment
towards prevention; compared to the Control condition, we will learn if TSM for School Adults is by itself an
effective intervention. Similarly, analysis of the outcomes for participants in Condition A will provide information
on the efficacy of the combination of TSM for School Adults and classroom instructional time. Finally, because
educating youth to prevent PSB will always remain an important learning goal for this age group, direct
comparison of Condition A to Condition B will yield information about the relative value of added classroom
instructional time compared to TSM for adults only. Key innovations include TSM’s adult-focused training
component, a rules-based approach, a flexible delivery model requiring less instructional time, and a dual
focus on preventing negative outcomes while promoting positive developmental competencies. Methodological
innovations include examining cumulative and cross-sectional effects across three student cohorts and
evaluating practices for Safe Adult and Safe Peer-to-Peer Communications to prevent CSA and PSB.

Public health relevance
Project Narrative Child sexual abuse (CSA) and problematic sexual behavior (PSB) among youth are significant public health issues with far-reaching physical, emotional, and societal consequences. Using a randomized control trial with delayed rollout, this research will evaluate the effectiveness of Teen Safety Matters (TSM), a school-based prevention program aimed at equipping middle school adults and students to identify and prevent CSA and PSB, with a focus on diverse, urban populations. This research will provide critical evidence to inform CSA and PSB prevention strategies in school—addressing health inequities in a broadly diverse communities—and contribute to the CDC’s mission by advancing scalable, evidence-based prevention solutions to improve youth safety and well-being.